Microglia-mediated adverse effect of cannabis on prefrontal cortex maturation and cognitive function

Adolescent heavy cannabis use increases the risk of impaired cognitive and executive functions. Clinical
evidence indicates an adverse effect of chronic cannabis use on impulsivity, which is critically regulated by
inhibitory control in executive function. The adverse effects of cannabis are mainly attributed to delta-9-
tetrahydrocannabinol (THC), which primarily targets cannabinoid receptor type 1 (CNR1). The potency of THC
in cannabis has increased in recent decades, posing a growing concern in society. Importantly, recent studies
indicate CNR1 expression not only in neurons and astrocytes but also in microglia actively participating in
adolescent maturation of the prefrontal cortex (PFC). Nevertheless, whether and how microglia mediate THC-
induced aberrant adolescent PFC maturation, leading to impaired cognitive and executive functions remains
poorly understood. This proposal aims to address these knowledge gaps by leveraging our recent work. We
have reported that adolescent THC exposure induces amoeboid-like reactive morphological changes in
microglia, specifically in the medial PFC (mPFC), which are exacerbated in a mouse model with a genetic risk
factor for neuropsychiatric disorders. These effects are mediated by microglial CNR1, reducing the excitability
of a particular type of excitatory neurons in mPFC called pyramidal-tract (PT) neurons. However, it is not yet
known how adolescent THC exposure affects microglia function at the molecular level, what intercellular
mechanisms direct the effects of THC on microglia-mPFC neuron interaction in a neuron subtype-specific
manner, and whether hypoexcitability of PT neurons contributes to deficits in long-term cognitive and executive
functions induced by adolescent THC exposure. Previous studies suggest that up-regulation of the
cyclooxygenase-1 (COX-1)-prostaglandin E2 (PGE2) pathway in microglia is involved in reduced neuronal
excitability. The mPFC PT neurons mediate response inhibition, an essential element of inhibitory control. Our
preliminary data reveal that adolescent THC exposure induces up-regulation of the COX-1-PGE2 pathway in
mPFC microglia, reactive morphological changes of mPFC microglia, reduced neuronal excitability of PT
neurons, increased impulsivity, and deficits in response inhibition. Based on these findings, we hypothesize
that adolescent THC exposure up-regulates the COX-1-PGE2 pathway in microglia via CNR1-mediated
mechanisms, and that PGE2 secreted from microglia acts on neuronal PGE2 receptors and alters PT neuron
maturation, thereby reducing their neuronal excitability. These mechanisms may be adolescence- and neuron
subtype-specific, leading to deficits in response inhibition. To address these hypotheses, we will identify the
time course of CNR1-mediated molecular and morphological changes in microglia induced by adolescent THC
exposure. We will also identify the microglia-mediated mechanisms underlying adolescent THC-induced
aberrant mPFC neuronal maturation. Finally, we will identify the specific neuronal circuits of mPFC PT neurons
contributing to increased impulsivity and deficits in response inhibition induced by adolescent THC exposure.

Public health relevance
Narrative Clinical evidence indicates adverse effects of chronic cannabis use on impulsivity, which is critically regulated by inhibitory control in cognitive and executive functions. The escalating potency of THC in cannabis raises serious concerns about its impact on youth mental health. The proposed work aims to provide important knowledge about the unexplored microglia-specific mechanisms underlying the adverse effects of THC exposure on adolescent prefrontal cortex maturation and inhibitory control in adulthood.